RACIAL AND ETHNIC DISPARITIES IN HUMAN SERVICES ANALYSIS EXECUTION PROJECT

This project will implement the research design plan from OPRE's previous Racial and Ethnic Disparities in Human Services project for up to four (4) ACF programs. The project will use existing program administrative and survey data (including microsimulation models) to identify and analyze racial and ethnic disparities. There is an option to further extend this work into the collection of new data to supplement and deepen the analysis.The goal of this project is to improve ACF program delivery for all racial and ethnic groups. The project will use the results of the analyses to develop briefing papers.